Program Development (Pilot) Core

Project Summary
Core B is the heart of CDHA’s research contribution. Through this core we select and prioritize strategic areas
of research and maintain and develop a sound and reliable set of operations to identify, evaluate, rank and
allocate seed funds for innovative, high risk pilot projects that are consistent with NIA research priorities and
CDHA’s mission. Core B also ensures an efficient system to overview the progress of funded pilot projects so
that they lead promptly to submission of larger projects to granting agencies. Finally, through this core we
build additional support for program development by seizing opportunities within the University (Office of
Vice Chancellor of Research and Education, College, and other centers) and outside UW-Madison campus with
private foundations or other federal agencies.

Public health relevance
Project Narrative Per funding announcement instructions, the narrative is located in the Overall section of this proposal.